Exosomes as mediators of cardiac injury and repair

Summary
For a complex organ like heart, well-organized interactions between different cell types are essential for its
effective functioning. Cell-cell communication between these myriad cell types therefore appears to be key
component of cardiac function and a better understanding of how different cells within injured myocardium
communicate with each other during homeostasis and injury and elucidation of molecular events downstream
of such communications is critical to identify new therapeutic targets for cardiac healing after injury. Increasing
evidence suggest that extracellular vesicles (EVs) including exosomes are major paracrine conduits of cardiac
cell-cell communication in homeostasis and disease conditions. However, a comprehensive understanding of
how cardiac injury alters exosome-mediated cell-cell communications both locally within myocardium and at
long distance organs such as bone marrow and adipose tissue and whether these exosome-mediated
alterations in cell-cell communications influence overall cardiac structure and function and repair is not well
understood. The overarching hypothesis of this renewal application is that cardiac injury alters exosome-
mediated specific cell-cell communication both locally within the injured myocardium and distally with other
organs and these intra-cellular and inter-organ communications influence overall myocardial responses to
injury and repair processes. To test our hypothesis, we have assembled a team of highly accomplished
scientists who have the potential to markedly advance the science and application of exosome biology for
ischemic tissue repair. In particular, the design of this program, highlighted in inter-related yet unique individual
projects, intends to capitalize on our existing synergy and assets. We will utilize the advantage of strategically
designed scientific cores that will support each project. We will apply various techniques of molecular, cellular,
and biochemical approaches in cell models and mice models of myocardial injury and repair. Project 1
(Kishore) examines the role of stressed cardiomyocyte-derived exosomes, particularly cardiomyocyte specific
microRNAs, on post-injury endothelial and endothelial progenitor cell function and angiogenesis. Project 2
(Walter Koch) focuses upon the involvement of cardiac exosomes containing G-protein coupled receptor kinase
2 on adipocytes and cardiac cell function. Project 3 (Tilley) examines the role of beta-2 adrenergic receptor on
myeloid cell exosomes and cardiac functions. All three projects involve in-depth molecular, cellular, and
physiological studies comprising of mouse models of myocardial injury. Establishing the role of exosomes in
post-injury cell to cell communications may identify new mechanisms and therapeutic targets for post-injury
myocardial repair. The goal of this program will be to delineate exosome mediated signaling mechanisms and
determine how they can be utilized to restore and enhance endogenous cellular repair processes that heal the
damaged heart.

Public health relevance
Narrative For a complex organ like heart that harbors large number of different cell types, a coordinated communication between individual cells is of paramount importance for efficient functioning of the heart. Extracellular vesicles or exosomes, small vesicles secreted by most cells are important mediator of cell to cell communication both within heart and with other cells/organs at long distance. This program will comprehensively characterize how after heart injury individual cell- derived exosomes communicate with other cells in heart and at long distance and how these communications affect overall heart repair after injury and hopefully will identify new mechanisms and therapeutic targets to enhance heart repair.